COVID supplement: A multi-site study seeking to study immune responses developed after infection with SARS-CoV-2

The Georgia University Research Foundation to support the National Cancer Institute's multi-site study seeking to determine if immune responses developed after confirmed infection with SARS-CoV-2.